9/14 APOL1 Long-term Kidney Transplantation Outcomes Network (APOLLO) Clinical Center

PROJECT SUMMARY/ABSTRACT
Successful kidney transplant reverses many of the chronic abnormalities in chronic kidney disease (CKD) and
has shown to improve not only quality of life but also patient survival compared to renal replacement therapy. It
is vital to identify strategies that improve and prolong organ function. APOL1 risk alleles have been shown to
explain in part the increased risk of African Americans compared to non-African American for end-stage kidney
disease. However, the association of APOL1 alleles with kidney transplant outcomes such as deterioration of
kidney function, acute rejection, and allograft loss as well as living donor health is unclear. APOL1 genotyping
has the potential to reduce the discard of good-quality kidneys from AA donors and increase the number of
transplants overall. We are responding to RFA-DK-22-506 – “APOL1 Long-term Kidney Transplantation
Outcomes Network (APOLLO) Clinical Centers”, to continue as a clinical center that builds upon the
accomplishments of our established multidisciplinary research group in the first phase. As a successful
recruitment site with our aligned 19 transplant programs, the proposal builds upon an established infrastructure
and our experience recruiting APOLLO participants. In Phase 1 of APOLLO, we have successfully consented
156 kidney transplant recipients and 12 living donors, with DNA on hand in 151 recipients (97%) and 12 donors
(100%), across these centers.
We propose to collect long-term follow-up data on all APOLLO participants. (Aim 1); to provide detailed clinical
data and biospecimens on APOLLO participants from our CC providing unique data not available in national
registries: kidney biopsy results, acute rejection types and treatment, recurrent disease, changes in
immunosuppression, medical compliance, bacterial and viral infections, proteinuria, creatinine and donor
specific HLA antibodies, among others (Aim 2); and to facilitate return of APOL1 genotype results to
participants (Aim 3). We are committed to collaborative protocol development, sharing best practices, and
team science to achieve the APOLLO’s objectives. The APOLLO network has established a high-quality
resource (data and specimen repository of blood, urine, DNA, and RNA) for future basic, clinical and
translational research in transplantation. The proposed research plan will have future diagnostic, prognostic
and therapeutic implications. In addition, it could have policy implications as kidneys may need to be allocated
in the future taking into account the donor APOL1 genotype. The proposed research plan, by improving our
understanding of the impact of APOL1 gene in kidney transplantation, has the potential to dramatically impact
public health and diminish kidney discards for transplantation.

Public health relevance
PROJECT NARRATIVE APOL1 genetic variations have been shown to explain in part the increased risk of African Americans compared to non-African American for end-stage kidney disease. However, the association of APOL1 high risk alleles with kidney transplant outcomes such as change of kidney function, acute rejection and graft failure is unclear. We propose to determine if the presence of APOL1 risk alleles in donor and recipients is associated with recipient kidney transplant outcomes as well as determine the impact of kidney donation for individuals with APOL1 risk alleles.